Gprasp2 expression identifies a deeply quiescent hematopoietic stem cells subset with superior stemness and self-renewal

Project Summary
Hematopoietic stem cells (HSCs) are a rare pool of self-renewing, multipotent cells residing in the bone marrow
that support lifelong blood production. HSCs can be transplanted into ablated recipients, where they can
reconstitute all hematopoietic cell types, making them highly useful as a curative therapy for patients with
hematopoietic diseases via HSC transplantation. To sustain lifelong blood output and meet emergency demands,
HSCs tightly regulate a quiescent versus cycling state to protect from exhaustion. A deeply quiescent HSC
subset has been identified that rarely contributes to steady-state hematopoiesis, preserving the long-term fidelity
of the HSC pool. Upon transplantation, deeply quiescent HSCs display increased self-renewal and stemness,
suggesting these HSCs may be highly relevant to transplant outcomes. However, little is known about the
relationship between HSC quiescence and cell fate and few molecular markers of deeply quiescent HSCs exist.
My goal is to identify novel molecular markers of deeply quiescent HSCs for mechanistic interrogation.
We recently identified GPRASP2 (G-protein Coupled Receptor-associated (GPCR) Sorting Protein 2), an HSC-
enriched protein involved in GPCR trafficking, as a regulator of HSC transplantation. Pilot single HSC
immunofluorescence studies reveal heterogeneous HSC Gprasp2 expression and single-cell RNA sequencing
(RNAseq) data show low Gprasp2-expressing HSCs are enriched in lineage-specific differentiation and cell cycle
programs relative to Gprasp2high HSCs. We generated Gprasp2 reporter mice to interrogate HSC subsets based
on Gprasp2 expression (Gprasp2low/Gprasp2high). Preliminary transplant data reveal Gprasp2high HSCs display
slow blood repopulation kinetics and robust, lineage-balanced reconstitution compared to faster, less robust, and
lymphoid-biased reconstitution by Gprasp2low HSCs. Bulk RNAseq and pathway analysis reveal Gprasp2high
HSCs downregulate cell cycle and cellular responses to stimuli gene expression. Consistently, more Gprasp2high
HSCs occupy G0 than Gprasp2low HSCs and display greater self-renewal during ex vivo culture. I hypothesize
Gprasp2 is a novel marker and regulator of a deeply quiescent HSC subset that preferentially self-
renews. In Aim 1, I will test if Gprasp2 marks a subset of deeply quiescent HSCs by assaying in vivo division
history of Gprasp2low/high HSCs, quantifying exit from quiescence upon stimulation, and interrogating
reconstitution kinetics post-transplant. In Aim 2, I will use serial transplantation and single-cell assays of self-
renewal and cell fate to test if Gprasp2 predicts cell fate. In Aim 3, I will investigate if Gprasp2 is a driver of HSC
self-renewal by modifying Gprasp2 expression and identify GPCRs and cell-surface receptors with known roles
in hematopoiesis regulated by Gprasp2 via proximity labeling assays. Completion of these aims will produce
data for peer-reviewed publication and give mechanistic targets as preliminary results for a K99/K00 application.
The McKinney-Freeman laboratory at St. Jude is the optimal training environment for gold-standard HSC assays,
proteomics approaches, and bioinformatics required for my career as an independent HSC investigator.

Public health relevance
Project Narrative Hematopoietic stem cells (HSCs) are responsible for the production of blood throughout life and single-cell technologies have revealed blood production may not be supported by a single type of HSC with flexible output, but rather by a heterogeneous mix of stem cells with distinct capacities for self-renewal and differentiation. This project will identify Gprasp2 as a novel molecular marker of a deeply quiescent HSC subset with superior capacity for self-renewal and stemness. The identification of molecular markers of deeply quiescent HSCs will greatly aid in studying the molecular regulation of HSC self-renewal and protection from exhaustion during homeostasis, stress, and disease.